Androgen Regulation of CRF Receptor 1 as a mediator of stress responses

Project Summary
There are striking sex differences in stress/mood associated disorders, such as anxiety and depression with
women showing 2-3 fold greater prevalence than men. These differences are believed to be regulated by sex-
specific patterns of gonadal hormone exposure and their subsequent effects on brain circuitry. In particular,
androgen actions through the cognate androgen receptor (AR) have been shown by our lab and others to
suppress the release of stress hormones and decrease stress-related behaviors associated with anxiety and
depression. However, the specific neural mechanisms through which androgens act to produce these effects
remain largely unknown. Recent studies in our laboratory and others have demonstrated that cells expressing
corticotropin releasing factor receptor 1 (CRFR1) are likely critical for androgen regulation of stress responses.
CRF signaling through CRFR1 is widely known to regulate anxiety- and depressive-like behaviors as well as
activation of the hypothalamic pituitary adrenal (HPA) axis which controls stress hormone (e.g. glucocorticoid)
secretion. Our laboratory has demonstrated high levels of AR within CRFR1 neurons in key stress regulating
brain regions in the mouse that have previously been implicated as sites for androgen regulation of stress
functions ((paraventricular hypothalamus (PVN) and ventral bed nucleus of the stria terminalis (BSTv)). We
propose to determine the role of AR, specifically within CRFR1 neurons of the PVN and BSTv, in regulating
stress-associated behaviors and the HPA axis. This will be accomplished using a Cre mouse line and viruses
designed to knockdown or overexpress AR within Cre-expressing neurons. Overall, we expect these studies will
identify critical cell groups that regulate stress-related functions, thus aiding in our understanding of the
neurobiological roots of related human disorders, including depression and anxiety.

Public health relevance
PROJECT NARRATIVE The androgen receptor (AR) plays a prominent role in regulating stress-related behaviors associated with anxiety and depression, and stress hormone release. Evidence, including recent work in our laboratory, indicates that cells expressing corticotropin releasing factor (CRFR1) within two stress-regulating brain regions (paraventricular hypothalamus and bed nucleus of the stria terminalis) may be critical to androgen regulation of these functions. We will perform experiments to determine the role of AR within CRFR1 neurons of these brain regions in controlling stress-related functions and ultimately this work will enhance our understanding of how androgens might contribute to sex differences in anxiety and depression reported the human population.